Developing and Testing a Novel Multidimensional Stigma-Resilience Measure for Stigma Reduction Research with Black Men Who Have Sex with Men

ABSTRACT
Black men who have sex with men (BMSM) continue to experience disproportionate burdens of HIV compared
to other MSM subgroups in the US. This disparity is exacerbated by the multilevel intersectional stigmas that
BMSM face, including those based on race, same-sex attraction/behavior, and presumed HIV-positive status,
which results in high levels of psychological distress and poor HIV prevention outcomes. Resilience is a critical
component in studies to mitigate the negative impact of multilevel intersectional stigmas on HIV prevention
uptake among BMSM. However, existing resilience measures are designed for non-marginalized populations
and are inadequate for assessing BMSM's resilience to multilevel intersectional stigmas. To address this gap,
we propose to develop a novel, BMSM-specific, multidimensional stigma-resilience scale that captures the
nuanced resiliency mechanisms countering intersectional stigmas across multiple socioecological levels. The
proposed study will be conducted in Nashville, an HIV hotspot in the Southern US, where growing HIV burdens
and intersectional stigmas among BMSM have been identified. The study has two specific aims. In Aim 1, we
will define the mechanisms of multidimensional resilience that BMSM use to counter intersectional stigmas. We
will conduct in-depth interviews with 30 HIV-negative BMSM in Nashville, guided by a conceptual framework that
integrates the Socioecological Model, Resilience Theory, and Intersectionality Framework. We will explore how
resilience is developed, manifested, and implemented to overcome intersecting forms (e.g., internalized, enacted,
experienced, and anticipated) and types (e.g., stigma against racism, homosexuality, and presumed HIV status)
of stigmas across multiple socioecological levels (e.g., individual, interpersonal, community and healthcare). Aim
2 will necessitate an iterative and systematic BMSM community engagement process to develop and validate a
new multidimensional stigma-resilience measure tailored for BMSM. Insights from Aim 1 will help inform the
adaptation of an existing scale (e.g., Multilevel Resilience Measure for Black Adults Living with HIV) to be
contextually appropriate and stigma-focused for BMSM. We will then assess face validity and cultural relevancy
through cognitive interviews with 10 BMSM, followed by conducting psychometric analyses with 250 BMSM to
test the new scale's reliability (e.g., internal consistency) and validity (e.g., convergent, divergent, and predictive
validity). The proposed study is significant in providing a robust, culturally-tailored stigma-resilience measure,
which will inform our future R34/R01 study to develop and evaluate a multilevel resilience-based intervention to
mitigate intersectional stigmas and HIV prevention uptake among BMSM. Additionally, the new BMSM
Multidimensional Stigma-Resilience Scale will provide the groundwork for future studies to refine and adapt the
scale for resilience-focused research conducted with other marginalized populations (e.g., Latino/Hispanic MSM;
transwomen of color).

Public health relevance
PROJECT NARRATIVE Intersectional stigmas due to black race, same-sex attraction/behavior, and presumed HIV-positive status threaten the HIV prevention uptake and well-being of Black men who have sex with men (BMSM). Building resilience to intersectional stigmas is critical for BMSM to mitigate psychological distress and enhance engagement in the HIV prevention continuum. The proposed project seeks to (1) define the nuanced resiliency mechanisms in countering intersectional stigmas at multiple socioecological levels; (2) develop and validate the first multidimensional stigma-resilience measure tailored for research conducted with BMSM.